Optimizing fertility preservation and decision quality in male AYA with cancer: A family-centered intervention

Summary/Abstract:
There is a growing population of childhood cancer survivors in the U.S. and 1 in 2 male survivors has impaired
fertility. Although pubertal males are able to bank sperm, only 25% of adolescents opt for fertility preservation
(FP) prior to cancer treatment. As these adolescents and young adults (AYA) complete therapy and approach
their reproductive years, many survivors and their parents regret missed opportunities for FP and report
distress about potential infertility. With the majority of studies conducted years after therapy, there is limited
information about predictors of FP among AYA males, in addition to decision quality soon after FP decisions
are made. Further, most of the interventions in this area have focused on increasing knowledge and improving
patient-provider interactions, without accounting for parent-adolescent discussions about FP. Notably, recent
research has shown parents' recommendation is one of the strongest predictors of FP uptake among AYA
males. The relative ease but underutilization of sperm banking and the psychosocial implications of infertility
demonstrate a need for novel family-centered interventions to optimize FP uptake and decision quality for this
unique and vulnerable population. My long-term goal is to become an independent clinician-scientist committed
to improving reproductive potential and quality of life for childhood cancer survivors. This application proposes
two studies (each with two visits), among AYA males (ages 13-21) newly diagnosed with cancer and at risk for
infertility, and their parents. Study 1 is a mixed methods, prospective study at the time of cancer
diagnosis in 40 AYA and their parents, to examine the impact of individual and family factors based on the
Health Belief Model, in the context of communication (quality of communication, provider/parent
recommendation to attempt FP), on FP uptake and decision quality. Findings will inform the development of a
family-centered psychoeducational intervention to be piloted in a randomized-controlled trial (RCT) in
Study 2 among 40 AYA and their parents. My career development plan includes a strong multidisciplinary
mentorship team, formal coursework, and seminars in three main focus areas: 1) mixed method, multi-
informant behavioral research, including hands-on training in qualitative interviewing and qualitative data
analytic methods; 2) family systems and communication regarding FP decisions; and 3) the design,
implementation, and analysis of clinical trials. Nationwide Children's Hospital is the ideal setting for this
research since there is large AYA Oncology program, valuable resources available in the Research Institute,
and strong institutional support for clinical research. Additionally, I serve as the medical director of the fertility
team and oversee the clinical consult service, facilitating successful recruitment of families at time of diagnosis.
Findings from the proposed research and training will support an R01 to test the intervention in a larger multi-
site randomized-controlled trial (RCT). This line of research will greatly enhance reproductive outcomes, which
is consistent with NCI's goal to improve quality of life among cancer survivors.

Public health relevance
Project Narrative/Public Health Relevance Statement: This research is highly relevant to public health because infertility is a significant problem in a growing population of male childhood cancer survivors. Developing and testing a novel family-centered psychoeducational intervention prior to cancer treatment to optimize fertility preservation uptake and decision quality, will improve reproductive outcomes and enhance quality of life. This is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will extend human life and help to reduce the burdens of illness and disability, and specifically NCI's mission to reduce the burden of cancer morbidity and mortality.